NEUROENDOCRINE AND BIOGENIC AMINE RESPONSE TO FENFLURAMINE OR PLACEBO

Neuroendocrine catheter study designed to test whether the 5-HT released by fenfluramine will produce reliable neuroendocrine responses that will differentiate between normal controls and patients with affective disorders, OCD, and schizophrenia.